High-resolution multiplex localization of Alzheimer’s disease risk and resilience factors

What distinguishes persons with Alzheimer’s disease (AD) or other age-related cognitive impairments from
age- and sex-matched cognitively healthy individuals, and what distinguishes these two populations from those
who are of very advanced age with preserved cognition (e.g., Super Agers), has been intensely investigated for
decades. A multitude of techniques and approaches has provided key insights, but the consensus is that some
still-unknown combination of parameters is the most likely explanation. Recent systems biology studies have
identified genetic networks that are linked to AD risk, resilience, severity, or pathology, which can be consid-
ered “interactomes” that promote or protect against AD progression and pathogenesis, referred to here as the
m109 and the BIN1 interactomes. Recent studies examining these interactomes with targeted proteomics in the
human dorsolateral prefrontal cortex (dlPFC) have expanded this tight linkage to the proteomic level. As the
genomic landscape conferring either risk of, or resilience to, AD continues to be established, determining the
neuroanatomical expression patterns of the proteins encoded by these genes is critical. Moreover, how their
expression patterns relate to each other and to individual cell-types is crucial for understanding why these net-
works are implicated in AD. Furthermore, expression patterns of these interactomes may differ substantially in
regions with AD-linked pathology as compared to adjacent, pathology-lacking microregions. This application is
relevant to NOT-AG-19-033 and proposes three Aims that build upon recent RNAseq/genomic/proteomic
studies using a combination of high-resolution immunolocalization techniques that will uniquely generate neu-
roanatomical expression patterns with multiplexed detail using both immunofluorescence array tomography
and immunogold electron microscopy in AD, asymptomatic AD, non-cognitively impaired, and Super Ager
dlPFC. The overarching hypothesis is that proteins encoded by the genetic risk/resilience interactomes are mis-
localized or aberrantly expressed in AD brain and cortical white matter with MRI abnormalities. Aim 1 will de-
termine the expression patterns of proteins encoded by the m109 and BIN1 interactomes in relation to synaptic
markers in the dlPFC neuropil. Aim 2 determine the expression patterns of proteins encoded by the m109 and
BIN1 protein clusters in relation to AD pathology in both the dlPFC gray matter and white matter. Aims 1 and 2
will also include examination of protein expression patterns in behaviorally characterized rodent models of AD
to establish cross-species validation of distributional motifs in human dlPFC and rodent prelimbic cortex. Aim
3 will determine the expression patterns of proteins encoded by the m109 and BIN1 protein clusters in relation
to the MRI abnormalities in human frontal and temporal cortex white matter. The main deliverable is to use
distributional motifs of risk and resilience factors, considered in aggregate with the most recent transcriptomic
and proteomic information from the Rush Alzheimer’s Disease Center and others, to identify high-confidence
hits for future mechanistic perturbation and therapeutic studies.

Public health relevance
Project narrative: As genetic networks strongly linked to cognitive decline and resilience continue to be revealed in humans and rodent models, neuroanatomical maps of their protein products with respect to each other will prove critical for advancing our understanding of Alzheimer’s disease (AD) and formulating testable functional models of the neurobiological impact these modules have on cognition, potentially streamlining drug candidate selection for treatment and/or prevention of AD. Moreover, the ability to provide high- resolution multiplexed co-localization maps of AD risk and resilience factors with voxel-conjugate mapping onto post-mortem MRI analyses will provide unprecedented insight into how the cellular composition of brain regions with pathology differs from adjacent, pathology-free regions.